Metabolic Dysregulation and Cancer Risk Program: Coordinating Center

PROJECT SUMMARY
The goal of the Metabolic Dysregulation and Cancer Risk Consortium (MDCRC) is to identify tangible
mechanistic/etiologic pathways that link obesity-related metabolic dysregulation with cancer risk to inform
cancer prevention strategies. The Consortium proposes to accomplish this through developing common
measures for obesity-related metabolic dysregulation for different cancer types, understanding how obesity-
related metabolic dysregulation affects cancer initiation and development, characterizing signal cross-talk
between key biologic processes that impact obesity-associated metabolic dysregulation and cancer risk, and
determining the utility of emerging approaches for the discovery of novel obesity-associated metabolic targets
in cancer risk and prevention.
The Biostatistics Center (Center) in the Milken Institute School of Public Health (SPH) of the George
Washington University (GW), the participating institution, proposes to serve as the MDCRC Coordinating
Center (CC). The MDCRC CC will integrate this expertise and experience, drawing upon our successful history
of coordinating center leadership in collaborative research consortia, capacity for innovation, and the extensive
scientific expertise in obesity and cancer prevention, nutrition, exercise, metabolism, body composition, and
bioinformatics/computational biology to form a CC that is rooted in scientific rigor and is flexible and responsive
to the diverse challenges and scientific opportunities of the MDCRC.
The specific aims of the MDCRC include to 1) provide scientific leadership and project management for
collaborative cross-Consortium activities, including providing guidance on the selection of common measures
and development of consistent protocols and manuals of operations, maintain private and public websites,
establishing topical work groups, and spearhead outreach activities; 2) facilitate data harmonization, data
sharing and results dissemination across the MDCRC sites and with NCI, including identification of
opportunities for novel data collection to enrich the MDCRC data resources, developing a common data
management platform, and training for site staff; and 3) establish a Self-Evaluation Core to promote timely self-
evaluation, along with effective self-correcting actions, working with NCI and the Consortium investigators to
establish criteria and outputs related to the “success” of individual investigators, study teams, and Consortium
sites.

Public health relevance
PROJECT NARRATIVE The Metabolic Dysregulation and Cancer Risk Consortium (MDCRC) is being created to study the biologic mechanisms by which obesity increases the risk of cancer in humans and will bring together several research groups studying how obesity alters normal metabolic pathways leading to cancer risk. The Consortium members will work together to identify common areas of data collection, and develop of a harmonized data set to accelerate research and discovery. The MDCRC Coordinating Center will facilitate the creation of this rich research data set, as well as provide both scientific leadership and project management for the collaborative cross-Consortium activities.